Post-Acute Care Transitions for Older Adult Medicare Beneficiaries with Serious Mental Illness

PROJECT SUMMARY/ABSTRACT
Roughly 1.5 million Medicare patients receive care in a skilled nursing facility (SNF) following acute
hospitalization each year. Older adults (65+ years) with serious mental illness (SMI) are a large and growing
segment of the SNF population, with specific needs that leave these individuals vulnerable to gaps or errors in
care. Understanding how older adults with SMI are connected to post-acute SNF care and how they transition
out of post-acute SNF care is essential to ensuring access to an appropriate level of services and high-quality
care across the continuum. To date, there has been little work characterizing the post-acute care (PAC)
trajectory of older adults with SMI. This study proposes two aims. First, I will (1) assess the extent to which
SNF placement patterns differ for patients with SMI. This is motivated by the concern that hospitals are known
to invest selectively with SNF partners in improved transitional care practices; if these investments are not
aligned with where patients with SMI are sent for care, care disparities may persist or worsen over time. To
assess SNF placement patterns, I will describe patterns of hospital to SNF discharge for older adults with and
without (a) narrow groupings of SMI (schizophrenia, bipolar disorder), and (b) broad groupings of SMI (narrow
SMI + major depression, anxiety, compulsive disorders) as compared to conditions targeted by the hospital
readmission reduction program (HRRP). Patients with HRRP conditions are a useful comparison group as they
represent populations where hospitals are most likely to have invested in high-quality care transitions to reduce
the risk of penalties for hospital readmission. I will use a discrete choice model to evaluate patterns of hospital
discharge to preferred-SNF partners to determine whether older adults with SMI have equitable access to
hospitals’ more preferred SNF partners, and if this is moderated by the presence of HRRP conditions. In my
second aim, I will (2) identify patient-, facility-, and county-level characteristics associated with discharge of
older adults with SMI to the community within the 100-day post-acute period. Characterizing factors associated
with return to community rather than conversion to long-stay (100+ days) is important given that services
provided in the home or community are of higher value and in alignment with patient preferences. I will use a
three-level mixed effects model to identify factors related to whether an older adult with SMI is discharged to
the community following a SNF stay. This research quantifies (1) how older adult patients with SMI sort into
SNFs; and (2) patient, facility, and county-level geographic factors associated with community discharge
following a SNF stay, an important component of high-quality care. By identifying where older adults with SMI
receive SNF care and how this influences their care trajectory, this work will generate key insights meant to
guide policymakers and organizational leaders in the evaluation and improvement of payment/incentive
structures and regulatory requirements that affect care delivery for this population.

Public health relevance
PROJECT NARRATIVE Older adults (65+ years) with serious mental illness (SMI) are a large and growing segment of the skilled nursing facility (SNF) population. This study estimates patterns of utilization of post-acute SNF services for older adults with SMI. Findings will facilitate policymakers and organizational leaders’ evaluation and improvement of payment/incentive structures and regulatory requirements that affect care delivery for this population.